Evaluating the Effects of HACRP

Project Summary
Hospital acquired conditions (HACs) are common, costly, and deadly. Despite recent reductions, HACs still
occur at a rate of 121 events per 1,000 discharges. Building on previous payment reforms to reduce HACs, the
Centers for Medicare and Medicaid Services initiated the Hospital Acquired Condition Reduction Program
(HACRP). However, the effect of expanding incentives for patient safety under the new HACRP is unknown.
The objective of the current proposal is to understand the impact of the HACRP on patient and system
outcomes and the specific strategies used by successful hospitals to improve under the program. Our proposal
will address the following three aims: Aim 1: Evaluate the effects of the Hospital Acquired Condition
Reduction Program on patient outcomes. We will evaluate the effects of the HACRP on both targeted
measures (e.g. patient safety indicators) and downstream outcomes (e.g. 30-day mortality and readmission).
We will examine how much administrative changes (e.g. increases in coded severity and changes to
denominator criteria) explain the impact of the HACRP. We hypothesize that the HACRP will lead to decreases
in targeted measures but will have an attenuated effect on downstream outcomes. We also hypothesize that
hospitals with more revenue at risk under the program and hospitals that are engaged in more value-based
reforms will experience greater improvements in targeted outcomes; Aim 2: Evaluate the effects of the
Hospital Acquired Condition Reduction Program on spending. We will evaluate the effects of the HACRP
on 30-day total episode spending as well as spending related to the index hospitalization, physician services,
readmissions, hospital outpatient care, and post-acute care services. We hypothesize that the HACRP will lead
to decreases in total episode spending as well as the downstream components of episode spending; Aim 3:
Evaluate the factors responsible for improvement under the Hospital Acquired Condition Reduction
Program. We will perform a case study analysis of hospitals in Michigan that participate in the Michigan Value
Collaborative, a partnership between BlueCross BlueShield of Michigan and 75 acute care hospitals in
Michigan working to improve quality and value. We hypothesize that hospitals that are engaged in systematic
quality improvement efforts will experience greater improvements on both targeted performance measures and
downstream patient outcomes. Our study is significant because our findings will be used to inform decision
makers at the CMS about the impact of new reimbursement mechanisms on quality, safety, and spending. Our
findings will also provide hospitals and clinician leaders with actionable insights about how to improve HACs.
Our study is innovative because it uses unique data linkages, provider collaboratives, and multiple methods to
evaluate upstream and downstream effects of a key policy reform.

Public health relevance
Project Narrative The proposed project is relevant to public health because it would provide crucial information to inform the implementation of the Hospital Acquired Condition Reduction Program in future years to improve patient and system outcomes. Given the size of the Medicare program and the national implementation of the Hospital Acquired Condition Reduction Program, even minor improvements to its design have the potential to improve the health and patient experience of thousands of older Americans. Successful completion of the proposed project would advance AHRQs effort to make health care safer and more affordable.